Institutional Career Development Core

I. INSTITUTIONAL CAREER DEVELOPMENT CORE (KL2)
SUMMARY/ABSTRACT
The Indiana Clinical and Translational Sciences Institute (CTSI) has a sustained record of accomplishment of
training KL2 Scholars through its Career development, Education and Research Training (CERT) Program.
Notably, CERT has trained 47 KL2 Scholars, with most retained in academic positions (92%), spending a
median of 75% of their time in research, being promoted to Associate Professor (43%), and obtaining external
funding as principal investigators (95%) including 14 R01s, 7 other R-level awards and 15 K or equivalent
career awards. These 47 Scholars have come from 29 different disciplines, have been diverse in terms of
gender (46% women) and race/ethnicity (15% underrepresented minorities), and are nicely distributed across
the spectrum of T1 through T4 research. An additional strength is the fact that our Scholars are recruited from
the 3 major research universities in the state: Indiana University, Purdue University, and the University of
Notre Dame. This expands the pool or Scholars, faculty mentors, and breadth of translational research. In this
application, we propose a number of new and innovative training initiatives that build upon our foundational
programs. We designed the four specific aims of the KL2 Career Development Core Program to maximize its
impact on the training and career development of clinical and translational scientists at an institutional,
regional, and national level. 1) Increase the flexibility and reach of our foundational programs for personalize
research training and accelerate mentored-to-independent investigator (K to R) status. 2) Add training in areas
where our CERT program has unique strengths as well as gaps. Key domains include implementation,
community-engagement, regulatory affairs, and population health. 3) Develop research training in 3 new areas:
team science, entrepreneurship, and experiential learning. 4) Test innovative training approaches through
research and national collaborations. We employ the continuous innovation cycle of “4Ds” in all of our CTSI
activities: Design, Demonstrate, Duplicate, and Disseminate. We also plan innovative initiatives that can serve
as model programs for dissemination more broadly. These include a) peer and community mentoring
programs to complement our already robust faculty-mentoring program: b) an inter-CTSA KL2 Scholar
exchange program; c) an I-Corps training course that serve regional CTSA programs; d) national
coordination of an on-line CTSA-industry training program in drug development conducted in collaboration
with Lilly, our founding industry partner. We are optimizing program evaluation utilizing NCATS common
metrics augmented with novel metrics. We are enhancing recruitment and retention of underrepresent
minority scientists, and offering a new course in translational research ethics.